Novel antiviral strategy offering forward capability and reduced risk of escape

ABSTRACT
The current coronavirus (CoV) pandemic, seasonal infections by other CoV and other “cold” viruses,
plus the need for annual influenza vaccinations exemplify the challenges posed by viral antigenic drift and shift.
Targeting landscapes of viral structural proteins displayed on the surfaces of virus particles and or the surfaces
of infected cells has been the primary basis for developing antibody-based therapeutics. Although great
advances have been made in trying to identify regions of these surface displayed proteins that are conserved
and less prone to “escape” antibody binding, it appears to be a continual battle of cat and mouse as we are
seeing with continual emergence of CoV “Variants of Concern”. In contrast, viral structural proteins that remain
inside virus particles and cells, avoid the impact of cyclical antibody selection, and tend to be far more
conserved. Oligomeric assemblies of these proteins can also blunt the impact of antiviral escape mutations
owing to the mix of mutant and wild-type monomers present in the parent cell. Furthermore, the stoichiometry
required of an antiviral to impede oligomer function need not be necessarily 1 antiviral to 1 monomer since,
especially if the antiviral were a crosslinker, its impact would be relayed beyond the immediate contact to
neighboring oligomers. Our long-term hypothesis is that affinity reagents capable of binding an internal
oligomeric structural protein of all species of a viral genus uniformly will impede viral assembly when present
as dimeric crosslinkers in a manner that is both forward capable and has much reduced susceptibility to viral
escape. We will explore the antiviral potential of dimeric crosslinkers using viruses of the genus Ebolavirus as
our model and a novel, rare nanobody manifesting uniform reactivity to nucleoprotein of all 6 species. Our two
specific aims are: (1) we will engineer mammalian cell expression vectors encoding nanobody homodimers
and assess antiviral activity using virus like particle surrogates at BSL-2 following plasmid transfection to drive
intrabody expression, (2) we will engineer E. coli expression vectors encoding nanobody homodimers fused to
cell penetrating peptides and glycosaminoglycan binding motifs and assess antiviral activity following protein
transduction of virus infected cells at BSL-4. Success will demonstrate a novel antiviral strategy that can then
be thoroughly explored for the propensity to select escape mutants relative to an existing neutralizing antibody
regime to test whether the strategy is more “escape-proof”. The overall approach should be applicable to other
human viral pathogens by carefully retuning the affinity reagent, with adequate time and resources, to
maximize broad long-term impact in helping to safe guard human health.

Public health relevance
NARRATIVE Many genera of viruses are comprised of different species, each continually evolving new exterior protein landscapes that can make broad spectrum countermeasure development very challenging. We have developed novel nanobodies that target interior proteins which are less prone to evolution and enable uniform binding of all species of the genus Ebolavirus. Our goal is to explore the antiviral potential of these nanobodies in in vitro tissue culture systems to determine if they can inhibit a broad spectrum of ebolaviruses that have emerged over the past 45 years.